Bright IDEAS-Young Adults: Problem-Solving Skills Training to Reduce Distress among Young Adults with Cancer

Project Summary/Abstract
Young adults with cancer experience more emotional distress and greater impairments in health-related
quality of life (HRQOL) than older patients. Cancer diagnosis during young adulthood interferes with participation
in normal developmental tasks such as obtaining higher education, starting a career, establishing financial
independence, and developing romantic partnerships. This disruption in normal activities coupled with the
unfamiliar and challenging demands of cancer treatment results in emotional distress and reduced HRQOL.
There is an urgent and critical need to develop, test, and implement evidence-based interventions to support
these young adults as they navigate perhaps the most challenging and debilitating period of their lives.
Current psychosocial care does not adequately address the unique concerns of young adults. An optimal
solution would give young adults the skills to deal with diverse and numerous stressors, address underdeveloped
problem-solving ability characteristic of this age group, and be relatively simple to learn and use during the highly
stressful time following a diagnosis of cancer. To address these clinical care gaps, this project will evaluate the
efficacy of a problem-solving skills training intervention developed specifically for young adults and grounded in
the core tenets of problem-solving therapy. “Bright IDEAS-Young Adults” (Bright IDEAS-YA) draws upon and
notably extends prior research demonstrating the efficacy of a cognitive-behavioral problem-solving skills training
program for reducing emotional distress in caregivers of pediatric patients. Bright IDEAS-YA is a 6-session, one-
on-one face-to-face intervention that teaches patients a systematic approach to overcome personal challenges
across any life domain. It aims to enhance patients’ problem-solving ability in the face of significant stressors
such as cancer. In preliminary work, young adults with cancer found Bright IDEAS-YA acceptable, relevant, and
useful. Patients who received Bright IDEAS-YA showed improvements in problem-solving ability and reductions
in symptoms of depression and anxiety. In the proposed project, we will conduct a multi-site randomized
controlled trial of Bright IDEAS-YA compared with enhanced usual psychosocial care with 300 YA patients (ages
18-39 years) undergoing cancer treatment. We will evaluate efficacy and examine mediators and moderators of
intervention effects using assessments at baseline, post-intervention (3 months), and follow-up (6 and 12
months). We hypothesize that young adults who receive Bright IDEAS-YA will report improved problem-solving
skills, lower distress (i.e., depression and anxiety), and better HRQOL compared with enhanced usual
psychosocial care. The proposed study aligns with the National Cancer Institute’s Division of Cancer Control and
Population Sciences mission to reduce the burden of cancer and enhance the quality of life of patients and
survivors, particularly among vulnerable groups such as young adults.

Public health relevance
Project Narrative Young adult cancer patients experience more distress and greater impairment in health-related quality of life compared with older patients, but current psychosocial care does not address their unique needs. The proposed randomized trial will evaluate a novel problem-solving skills training intervention designed to enhance patient problem-solving ability, reduce distress, and improve health-related quality of life. Results will advance clinical practice to reduce the cancer burden among this vulnerable group. ! !